Evaluation of peer-delivered, integrated mental health and HIV support groups for stepped management of common mental disorders among Mozambican Youth Living with HIV

PROJECT SUMMARY
Youth living with HIV (YLWH) have high rates of mental health problems, and poor mental health is associated
with worse HIV care continuum outcomes. Though the evidence for mental health interventions effective at
improving mental health and HIV outcomes among YLWH is growing, data on whether they can be feasibly and
cost-effectively implemented is lacking, and integration of mental health care into routine HIV programming
remains rare. Mozambique, a low-income country, has the second highest number of new HIV infections in
Eastern and Southern Africa, and just 54% of YLWH there are currently on antiretroviral therapy (ART).
Recognizing the importance of mental health to optimal HIV care continuum outcomes, the Mozambican Ministry
of Health has begun scaling up the Common Elements Treatment Approach (CETA) for people living with HIV,
delivered by psychologists within the National Health System. CETA is a modular, transdiagnostic intervention
developed for use in low- and middle-income countries, with demonstrated effectiveness in treating common
mental disorders (CMD, i.e., depression, anxiety, PTSD) in Mozambican YLWH. However, like other high HIV-
burden contexts, the prevalence of CMD among Mozambican YLWH (~10-20%) exceeds the resources available
to deliver this already streamlined, individual intervention to all those needing care. To reduce the treatment gap,
there is an urgent need for effective, more efficient mental health treatment options for YLWH.
Leveraging our team’s research-service-policy partnership, we propose testing a novel, stepped-care
model to streamline mental health services for YLWH within the Mozambican National Health System. We aim
to integrate Interpersonal Psychotherapy-Adolescent Skills Training, an evidence-based intervention for youth
experiencing mild-moderate CMD, within existing peer-led HIV support groups to develop an evidence-based,
low-intensity intervention that simultaneously promotes mental health and HIV outcomes, i.e., CombinADO-MH
(Aim 1). We will then conduct a Hybrid Type I Effectiveness-Implementation cluster randomized control trial to
evaluate the clinical and implementation outcomes of delivering stepped care (CombinADO-MH for YLWH with
mild-moderate CMD symptoms, CETA for YLWH with severe CMD symptoms) compared to CETA alone (all
YLWH with mild-severe CMD symptoms). We hypothesize that CombinADO-MH will perform similarly to CETA
at reducing CMD symptoms, increasing ART adherence, and increasing viral load suppression (Aim 2) but will
have a greater reach and be a more cost-effective approach (Aim 3), producing greater overall benefits to YLWH.
Addressing NIMH Strategic Goals 3 and 4, this pragmatic trial will provide data on the effectiveness,
implementation, and cost of an innovative stepped approach to delivering evidence-based mental health care
using peer-providers and integrated within HIV support groups, which may efficiently and synergistically improve
mental health and HIV care continuum outcomes. Results can directly inform mental health and HIV
programming in Mozambique and may serve as a model for other resource-limited contexts.

Public health relevance
PROJECT NARRATIVE Youth living with HIV have high rates of mental health problems, and poor mental health increases their risk of non-adherence to antiretroviral therapy, poor engagement in care, and behaviors that promote HIV transmission. The proposed study will investigate the effectiveness and implementation of an integrated mental health and HIV support group intervention in Mozambique, a southeastern African country with the second highest number of new HIV infections in the region. Results of this study can inform mental health and HIV policy and service delivery in Mozambique and may serve as a model to improve health among youth living with HIV globally.